Predicting Short- and Long-term Risk of Serious Infections in Older Patients with Inflammatory Bowel Diseases

PROJECT SUMMARY/ABSTRACT
Despite rising incidence, prevalence and healthcare costs of inflammatory bowel diseases (IBD) in older
adults, there continues to be paucity of evidence-based treatment guidance for management of these
understudied and susceptible patients. The long-term goal is to inform evidence-based, risk-congruent
treatment approach for older patients with IBD, balancing patients’ dynamic risk of disease- vs. treatment-
related complications with specific treatment’s efficacy vs. safety. The overall objectives in this application are
to accurately predict the short- and long-term risk of serious infections with immunosuppressive therapy in
older patients with IBD, based on pre-treatment baseline clinical characteristics and time-varying treatment
effect. The central hypothesis is that pre-treatment clinical characteristics can accurately predict short-term risk
of serious infections in older patients with starting immunosuppressive therapy; this risk evolves over time, on
therapy, and can be accurately predicted by accounting for time-varying impact of treatment effectiveness. By
controlling disease effectively and decreasing the need for corticosteroids and/or opiates, an effective, yet
potent immunosuppressive therapy will be associated with lower risk of serious infections over time. The
rationale for this project is that accurate individualized risk prediction for treatment-related complications in
older adults with IBD on immunosuppressive therapy will provide patients and providers knowledge to tailor
therapy based on patients’ predicted risk of disease- and treatment complications. The central hypothesis will
be tested by pursuing two specific aims: 1) develop and validate a model that accurately predicts the short-
term risk of serious infections in older patients with IBD starting immunosuppressive therapy; and 2) develop
and validate a model that accurately predicts the long-term risk of serious infections in older patients with IBD
while on immunosuppressive therapy. Under the first aim, the applicant will develop and validate a risk
prediction model to accurately identify patients at high- vs. low-risk of serious infections in the short-term
(within 6 months of treatment initiation) based on pre-treatment baseline patient-, disease- and treatment
characteristics. For the second aim, a separate risk prediction model will be developed and validated to
accurately predict long-term (6 to 24 months after treatment initiation) risk of serious infections, accounting for
time-varying treatment effect, in older patients from the same cohort who have been on immunosuppressive
therapy for 6 months. The context for this proposal will be the comprehensive, longitudinal Danish nationwide
register of all older patients with IBD in Denmark. The research proposed in this application is innovative, in the
applicant’s opinion, because it incorporates time-varying treatment effect, in addition to patients’ intrinsic
susceptibility to infections, in predicting the dynamic risk of serious infections with immunosuppressive therapy
in older patients with IBD. The proposed research is significant because it is expected to fill a key evidence gap
in individualized prediction of treatment-related complications in a susceptible patient population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on providing personalized dynamic estimates of the risk of treatment-related complications, particularly serious infections, based on patient characteristics and treatment responsiveness when starting immune suppressing therapies for the management of inflammatory bowel diseases in older patients. Once these models have been developed, they offer potential for choosing the right treatment approach based on patient’s risk and treatment’s safety profile. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing illness and disability.